Host-pathogen interactions and carbon processing in glycerol kinase deficient Mycobacterium tuberculosis

Tuberculosis (TB) is the second leading cause of death due to infectious disease worldwide and is notoriously
difficult to treat. This is partially due to the emergence of drug-tolerant populations of Mycobacterium tuberculosis
(Mtb), the causative agent of TB. Drug tolerance, defined as a non-heritable phenotypic state of reduced growth
induced by stressors such as antibiotic treatment, differs from drug resistance, which is permanent and heritable.
The transient nature of drug tolerant populations provides a major barrier to identifying drug targets that kill Mtb.
Our lab identified a key glycerol kinase gene (glpK) as a major determinant of drug tolerance in Mtb driven by
reversible mutations in a homopolymeric region. These mutants are found in clinical samples and are associated
with poor clinical outcomes. Identifying novel drug targets against these clinically significant glpK mutants may
significantly improve the outcomes of TB treatment. However, little is known about the bacterial and host factors
that confer drug tolerance to glpK mutants in vivo. To study this clinically important phenotype, we generated a
H37RV glpK strain with a permanent drug tolerant phenotype. We found that glpK strain mimics classic
phenotypes of drug tolerant Mtb; glpK strain forms small colony variants, exhibits drug tolerance, overexpresses
genes related to dormancy, differentially expresses carbon metabolism genes, and accumulates intracellular
lipids. Given that glpK strain lacks a functional glycerol kinase, it is likely that glpK strain depends on carbon
sources other than glycerol for drug tolerance. However, most experiments are performed in glycerol-containing
media. As drug tolerance in Mtb is often associated with cholesterol accumulation and Mtb persistence requires
host cholesterol, we selected this biologically relevant condition to test the role of lipid metabolism on drug
tolerance in glpK strain. Furthermore, preliminary data suggest that macrophage infection can induce glpK
strain drug tolerance, but not all macrophage environments are equally likely to have a high drug tolerance
induction phenotype. We hypothesize that drug tolerance in Mycobacterium tuberculosis glpK mutants is
connected to alterations in lipid metabolism, which occur in vitro as well as in infected macrophages.
The goal of this project is to identify new drug targets in Mtb glpK mutants under biologically significant conditions
to improve translatability and unlock novel therapeutics that enhance the overall efficacy of TB treatment. To
identify novel drug targets under biologically significant conditions, we propose two models: a cholesterol-
containing media model (Aim 1) and a macrophage infection model (Aim 2). We will probe the essentiality of
relevant genetic pathways and genes within Mtb that are required for drug tolerance and then use specific
macrophage mutants as well as a library of genetically diverse macrophages to study how specific host
environments as well as a variable host genetic background affect bacterial drug tolerance. Together, these
studies will identify within pathogen, within host, and host-pathogen interactions, including genetic and metabolic
cross-talk, that regulate Mtb survival and drug tolerance, leading to novel drug targets against drug tolerant Mtb.

Public health relevance
PROJECT NARRATIVE Drug tolerance, a non-heritable, reversible state of slow growth which enhances survival to antibiotic treatment, is a major barrier to successfully treating Tuberculosis (TB), which remains the public health challenge of our time. This study will identify unique drug targets in a clinically significant, drug tolerant Mycobacterium tuberculosis (Mtb) strain lacking a key glycerol kinase (glpK), by assessing the role of lipid metabolism and host macrophage phenotypes on drug tolerance under biologically relevant conditions. This innovative project has the potential to greatly shorten the length of antibiotic regimens, reducing relapse as well as TB mortality by producing highly translatable data that will unlock impactful new treatments against a clinically significant strain of Mtb.